DIAGNOSIS OF PERTUSSIS BY MOLECULAR AND IMMUNOLOGICAL TECHNIQUES

There are several new methods for the detection of B. pertussis under investigation. Some of these involve the use of DNA probe technology and PCR. We propose a dual approach to the development of a DNA-based diagnostic test(s) specific for B. pertussis. One approach involves the further characterization of sequences associated with the porin gene to identify a short sequence which is unique to B. pertussis. The porin gene of B. pertussis has been cloned and sequenced by LP/CBER and preliminary evidence suggests that DNA sequences related to the porin gene unique for B. pertussis can be used as a primer for PCR amplification. Hybridization of Bordetella specific DNA probes to colony lifts from culture plates of suspected pertussis patients is also being developed. The objective of these studies is to develop rapid, sensitive and species-specific clinical assays for the detection of B. pertussis. Hybridomas producing monoclonal antibodies that specifically detect B. pertussis in clinical samples have been developed for the detection, by immunofluorescence, of infection in children suspected of having whooping cough. These monoclonal antibodies are being evaluated in the clinical environment.